Neuronal mechanisms of image processing in the early visual pathway

PROJECT SUMMARY
Images captured by our eyes are processed in the retina by separate ON and OFF pathways that signal light
and dark stimuli in visual scenes. The traditional thinking is that the two pathways converge in visual cortex and
their responses blend with eye movements, making it difficult to separate ON and OFF pathway function. Our
recent work and preliminary results challenge this traditional view by demonstrating that ON and OFF pathways
remain segregated in visual cortex, are differently modulated by the luminance contrast and spatiotemporal
properties of stimuli, and their function can be measured in the clinic from visual responses to the onset of light
and dark stimuli. Our recent work and preliminary results also indicate that the different stimulus preferences
from ON and OFF pathways are needed to sample the diverse light and dark stimuli in our visual world, but they
also make ON pathways more vulnerable than OFF pathways to low light and scenes that lack bright surfaces.
Low light and lack of outdoor vision are also major risk factors in myopia, a visual disorder that blurs vision at far
distance and is increasing at an alarming rate across the world. Based on our previous work and preliminary
results, we hypothesize that myopia emerges from an under-stimulation of ON visual pathways. In this proposal,
we will test this hypothesis by directly measuring the neuronal and visual function mediated by ON and OFF
pathways in humans with myopia and normal vision. In the first aim, we will take advantage of standard recording
methods already available in the clinic (electroretinography and electroencephalography) to measure the
difference in the stimulus tuning of ON and OFF pathways in humans. We will record neuronal signals dominated
by retinal interneurons (electroretinography) or retinothalamic pathways (electroencephalography) and
investigate how the human ON/OFF neuronal response balance changes with stimulus conditions. We will also
use automated photography to measure ON/OFF stimulation balance in outdoor visual scenes, which are
thought to protect against myopia progression. In the second aim, we will use new visual tests that we are
developing with head-mounted visual displays, wearable eye tracking, and electrically tunable lenses to measure
differences in human vision mediated by ON and OFF pathways. We will then and use these data to develop a
computational model that simulates myopia progression in different visual environments.

Public health relevance
NARRATIVE Human vision depends on the functional integrity of two major information pathways that originate at the very first synapse of the visual brain and signal the presence of light and dark stimuli in visual scenes – the ON and OFF pathways. Our recent work and preliminary results indicate that poorly-illuminated visual environments under-stimulate and weaken ON pathways, and the weak ON pathways increase the risk of developing myopia. In this proposal, we will investigate how the neuronal response balance of ON and OFF pathways changes with stimulation conditions and myopia. Our results could lead to new approaches for the prevention and treatment of this visual disorder that is predicted to affect half of the world population by 2050 1.